EFFECT OF PHOTOPERIOD ON GH SECRETION AND BODY COMPOSITION OF ANIMALS

This research will test the hypothesis that Growth Hormon mediates the effects of photoperiod on body composition in the golden hamster. The study will determine: 1) whether enhanced body weight gain in hamsters exposed to short days is associated with decreased GH secretion; 2) whether high-fat diets enhance short day induced body weight gain in hamsters by further suppressing GH secretion; and 3) whether treatment with GH-releasing hormone to enhance GH secretion will decrease short day and high fat induced weight gain.